Laying the Groundwork for Web-based Elemental Imaging Software: The MicroAnalysis Toolkit

PROJECT SUMMARY
Living organisms use fluxes in chemical elements to control fundamental processes such as metabolism,
homeostasis, the cell cycle, and fertilization. Up to 60 chemical elements can be detected in the human body,
25 of which are essential. Dysregulation of essential elements underpins neurological disorders, angiogenesis
and tumor formation in cancer, and immune response to infectious disease. Chemical elements are used in
disease diagnosis and treatment; gadolinium is a common magnetic resonance contrast agent, metal-based
nanoparticles show promise for drug delivery and platinum and arsenic compounds are chemotherapeutics.
Elemental imaging (EI) provides data for both the concentration and distribution of multiple chemical elements
in situ in the form of an image; accelerating understanding of a diverse range of bio-metallic mechanisms from
environmental to biomedical. EI furthers the NIGMS goal to support basic research that increases our
understanding of biological processes and lays the foundation for advances in disease diagnosis, treatment,
and prevention. However, EI techniques are challenging to both access and master. Laser ablation inductively
coupled plasma mass spectrometry (LA-ICP-MS) is a laboratory-based EI technique that it is increasingly
applied to biomedical applications with comparable or lower detection limits than other EI techniques. The
Dartmouth Trace Element Analysis Core (TEAC) is an established and highly regarded shared resource that
supports researchers throughout the US, is staffed by experienced researchers in EI and ICP-MS, using state-
of-the-art instrumentation and has excellent links to industry partners. In 2021 the TEAC expanded upon the
current ad hoc service to establish a dedicated biomedical EI user facility; the Biomedical National Elemental
Imaging Resource (BNEIR) (1R24GM141194). Our aim is to broaden access to EI techniques in biomedicine
by building upon the TEAC’s existing infrastructure, administration, instrumentation, and expertise. We consult
with Dr Sam Webb, Stanford Synchrotron Radiation Lightsource, to further adapt his freely available EI
software, the MicroAnalysis Toolkit, for LA-ICP-MS. Building upon the success of BNEIR and the collaboration
with the creator of the MicroAnalysis Toolkit to broaden interoperability of this popular EI software, the aim of
this administrative supplement is to complete the groundwork necessary to transition the MicroAnalysis Toolkit
to a web-based interface, where users can access their data from local sources or online repositories and
perform data visualization and analysis on a device independent platform. The ability to run the MicroAnalysis
Toolkit from an online interface would (1) remove financial barriers to, and simplify data processing for, BNEIR
users with limited experience in EI; (2) streamline the data pipeline for numerous X-ray data sources; (3) make
FAIR databases for legacy EI data possible: preventing legacy data from being lost; (4) establish a standard for
EI software interoperability in a rapidly growing analytical field, and (5) pave the way for online interfaces for
other EI software applications.

Public health relevance
N/A